External Innovative Network Core

Project Summary
The external innovative network Core C builds external contacts through three independent activities and,
together, all three activities define the three main goals of this core. First, we maintain, manage and improve a
networked current awareness service for research in the demography of aging (CAAR). Second, Core C
organizes regular workshops, conferences, and visits that are combined with substantive and methodological
workshops and conferences. Finally, the Core engages in other outreach activities, such as sessions on data
resources and displays at conferences and professional meetings.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is located in the Overall section of this proposal.